South Texas Alzheimer’s Disease Center Population Neuroscience

ABSTRACT – Population Neuroscience Core
The Population Neuroscience Core (PNC) of the South Texas Alzheimer’s Center (STAC) aims to advance our
understanding of the life course factors contributing to Alzheimer’s Disease and Related Dementias,
particularly in the understudied population of Mexican American Hispanic, who face an increased risk of the
disease. To achieve this goal, our team will conduct cutting-edge epidemiological and neuroscience research
to monitor the prevalence and incidence trends of health disparities in dementia, identify life-course risk and
protective factors contributing to dementia, identify suitable and cost-effective biomarkers for risk prediction,
and the develop culturally and linguistically appropriate tools for cognitive assessment in Mexican Americans
from South Texas. The PNC has exceptional resources from existing longitudinal population-based cohorts,
new studies focusing on Mexican Americans with deep phenotyping, and established national and international
collaborations. The PNC aims to additionally close the gap of representation of Mexican Americans in
epidemiological research. This will be achieved by the creation of a PNC sharing resource, where harmonized
data to UDS and other standards in dementia research will be shared with other ADRCs and the scientific
community. This setting allows the PNC to provide cognitively healthy controls for the Clinical and
Neuropathological Cores as well as other ADRCs. Finally, we will train MDs, PhDs, and other professionals in
population neuroscience, to develop skills in quantitative and qualitative research methods by leveraging local
and national level data. The PNC will develop these aims in close collaboration with all STAC Cores.
In summary, the PNC strategically positioned to be a national resource of valuable data from Mexican
American Hispanics living in South Texas, and an asset to collaborative research centered on Alzheimer’s and
related dementias research. We are fully integrated with the other STAC Cores to provide knowledge, data,
services, tools, and training to investigators across the Center, as well as the broader ADRC and scientific
community.